MONKEY MODEL OF HUMAN PAPILLOMAVIRUS HIV &SIV CONSTRUCTS

HIV, diarrheal diseases of children and sexually transmitted diseases infect mucosal surfaces and are associated with tremendous morbidity and mortality. Vaccines designed to protect against these pathogens must induce mucosal immune responses. To date, no single immunization strategy has proven to be satisfactory in generating the required immune response in mucosal secretions or tissues. The use of attenuated recombinant mucosal pathogens to deliver antigen to the mucosal immune system is a potentially important method of generating mucosal immunity. Dr. Andino's group has used recombinant DNA technology to produce chimeric polioviruses that may be used as vaccines. These viruses provide a method to deliver the appropriate antigens to mucosal surfaces and elicit specific immune responses in the desired anatomic location. We have begun testing the immunogenicity and stability of poliovirus constructs expressing HIV and SIV antigens in rhesus and cynomologus macaques. These studies have demonstrated that the oral immunization with the recombinant viruses results in infection of cynomologus macaques but not rhesus macaques. The recombinant viruses are stable in vivo and the immunization of these animals results in systemic and mucosal immune responses. Six cynomologous monkeys were immunized rectally with the new generation SIV recombinants and analysis of the immune responses of theses animals is underway. If this approach proves successful in eliciting mucosal immunity, the studies will be expanded to include vaccination against a variety of mucosal pathogens. *KEY*Simian immunodeficiency virus, Mucosal immunity, Recombinant poliovirus vectors